Training in Oncology Population Sciences (TOPS)

PROJECT SUMMARY/ABSTRACT
The Training in Oncology Population Sciences (TOPS) T32 program trains postdoctoral fellows to conduct
research at the T3 and T4 interface to translate knowledge from the laboratory and clinical trials into practice
and population health to reduce the burden of cancer. The need for translational research at the T3 and T4
interface stems from persistent disparities in cancer outcomes and implementation gaps between what is
possible in the context of clinical trials and what happens in routine practice. The TOPS program trains 3
postdoctoral fellows each year in collaboration with 31 faculty from across the 7 institutions of the Dana-
Farber/Harvard Cancer Center. Training provides fellows with the skills necessary to address the challenges
and opportunities brought about by the tremendous growth in the complexity of cancer care, precision
medicine, electronic health records, mobile health, machine learning and data sharing. The TOPS program has
3 strategies to achieve this overarching objective: 1) training in core methods and skills necessary for
investigation through coursework and participation in regular seminars, workshops and reading; 2) intensive
focus on a research project with close mentorship; and 3) training in professional and career development
skills that are a prerequisite for investigation including project development, grant writing, presentation, building
and working with diverse teams, running a dry laboratory, and the responsible conduct of research.
The TOPS T32 is a continuation of the successful R25CA092203 Program in Cancer Outcomes Research
Training (PCORT), which trained 52 pre- and post-doctoral fellows between 2002 and 2017. Funded as a T32
since 2017, TOPS is co-led by Dr. Nancy Keating, a primary care physician, and Dr. Jennifer Mack, a pediatric
oncologist. TOPS trains postdoctoral students with degrees in the fields of medicine, nursing, behavioral
science, pharmacy, economics, clinical epidemiology, health policy, informatics, and engineering for careers
dedicated to cancer-focused population science. The core of the program is a group of 31 faculty mentors
(inclusive of the co-PIs) and 14 emerging mentors with expertise in 1) qualitative research, survey research,
and patient-reported outcomes; 2) observational studies and comparative effectiveness; 3) intervention
studies; 4) clinical informatics, mHealth/eHealth, machine learning, and AI; 5) health policy, economics and
decision science; 6) implementation science; 7) health equity; and 8) computational biology. At the end of the
two-year training, TOPS program participants are well-equipped with the skills necessary to launch
independent research careers in cancer-focused population science and have access to the core resources of
the DF/HCC and the Harvard Catalyst program for translational research training. The TOPS co-directors and
are supported by a 6-member Steering Committee that includes leaders from each of the 7 institutional
members of the DF/HCC and 6 accomplished investigators in population science who will serve as Advisors.

Public health relevance
PROJECT NARRATIVE Research investigation in population science is essential to ensure that discoveries from molecular medicine and clinical trials translate to routine practice and ultimately decrease the population-level burden of cancer. The Dana-Farber Harvard Cancer Center’s (DF/HCC) T32 Training in Oncology Population Sciences (TOPS) program equips postdoctoral fellows with the skills necessary to evaluate cancer care quality and effectiveness, and to develop, test and implement interventions to improve care delivery thereby ensuring that T1/T2 discoveries translate across the T3/T4 bridge to achieve maximal impact on population health. Postdoctoral fellows pursue a two-year program of mentored research, coursework and professional skills training that supports innovation and leverages the expertise of DF/HCC faculty to prepare them for independent investigation in cancer-focused population science.